ATG9 scrambles lipids in concert with ATG2 lipid delivery to directly grow the autophagosome

Project Summary/Abstract
The autophagosome encapsulates cellular debris into double-membrane vesicles responsible for trafficking
this cargo to the lysosome for degradation, thereby maintaining cellular homeostasis. How the autophagosome
grows and particularly the method by which lipid is delivered to the growing structure has been a key area of
dispute. The model favored by our lab is direct delivery of lipid from a source membrane to the expanding
phagophore by the early-acting autophagy-related protein ATG2 that we have defined as a bulk lipid
transporter. If ATG2 is growing the phagophore through direct lipid transport, then there must be lipid flipping
activity that allows for the population of the inner leaflet of the bilayer. Due to the nature of lipid-flipping
proteins, they must span the membrane at least once to facilitate lipid crossover. ATG9 is the only
transmembrane protein required for autophagy, and its function remains to be determined. Preliminary data
from our collaborator shows that ATG9 is capable of flipping lipids in vitro without the presence of ATP, making
it a potential scramblase. This data, the reported direct interaction with ATG2, and the fact that ATG9
accumulates with ATG2 genes knocked out led to the hypothesis that ATG9 is a lipid scramblase on the seed
membrane that facilitates membrane expansion of the phagophore through direct lipid delivery by ATG2. This
project is designed to provide the training necessary to achieve a future career in independent research.
Further, this project will increase the understanding of a crucial cell biological process and in turn lay
the foundation for future therapeutic lines of inquiry.
This proposal outlines two aims – Aim 1: Determine whether ATG9 functions as a scramblase in vivo, and if
so, whether it is embedded in the donor or acceptor membrane during autophagosome expansion; Aim 2:
Evaluate the lipid composition of the autophagosomal membrane and ATG9 vesicles to trace the origin of the
lipids required for autophagosome formation. Aim 1 will assess changes in the biology correlating to
manipulation of the ATG9 protein by a powerful combination of biochemistry and microscopy techniques.
Disruptions in autophagy will be evaluated by several classic readouts of autophagy progression such as LC3
puncta formation and autophagy factor turnover (i.e. p62), and will allow for efficient screening of ATG9
mutants before submitting them to in vitro scramblase activity assessment. Aim 2 will leverage high resolution
quantitative lipidomics and several knockout cell lines that trap autophagosome morphological intermediates to
determine the membrane composition of the mammalian autophagosome for the first time. The composition of
the autophagosome is expected to approximate the composition of the source membrane. Finally, to separate
the autophagosomal membrane from contaminating cargo, styrene maleic acid (SMA) nanodiscs will be
employed to rigorously assess the lipids that comprise the autophagosome. This proposed study will contribute
new insight into the mechanism of autophagosome formation and answer a decades-long question in the field.

Public health relevance
Project Narrative Disruption of autophagic clearance and changes in autophagy gene expression has been implicated in several disease contexts including neurodegeneration, aging, cardiovascular disease and cancer. This project aims to reveal a fundamental mechanism that maintains cellular homeostasis across all mammalian cell types. New insights from the proposed research project have the potential to inform therapeutic applications.